Molecular mechanisms of sympatho-excitation in cardiovascular disease

Project summary/abstract
Cardiovascular disease is the leading cause of death worldwide, and overactivity of the sympathetic branch of
the autonomic nervous system (sympatho-excitation) plays a key role in the pathogenesis or progression of
numerous cardiovascular diseases. Overactivity of cardiac sympathetic neurons leads to increased release of
neuropeptide Y (NPY), the major neuropeptide in the heart. Excess NPY release has been correlated with worse
outcomes in heart failure, where it is speculated to be arrhythmogenic and contribute to sudden cardiac death.
Our long-term goal is to understand what molecular changes occur within cardiac sympathetic neurons during
sympatho-excitiation that contribute to the increased release of NPY in cardiovascular disease. The central
hypothesis of this grant is that increased NPY levels in sympatho-excitation are attributable to enhanced
trafficking, synaptic localization, and exocytic fusion of NPY-containing vesicles in postganglionic sympathetic
neurons. These studies represent a major change in research direction for the investigator who previously
studied neuropathic pain. We will utilize our novel high-resolution, live-cell imaging techniques developed to
study the dynamic regulation of nociceptors, and adapt them to investigating the pathological regulation of the
heart in cardiovascular disease. Using a compartmentalized chamber, we will co-culture sympathetic neurons
from the superior cervical ganglia of neonatal rats with ventricular myocytes to form neuro-cardiac junctions. The
central hypothesis will be tested using the following aims: 1) To observe the real-time relationship between
sympathetic neuron firing rates and release of NPY, 2) To determine whether the formation of neuro-cardiac
junctions enhances the trafficking of NPY-containing vesicles to and capture within synaptic varicosities, and 3)
To determine whether sympathetic neurons from a neurogenic model of cardiovascular disease (spontaneously
hypertensive rats; SHRs) exhibit increased baseline excitability, including increased release of NPY. The results
of these innovative studies will represent the first report of the dynamic regulation of vesicular trafficking and
neuropeptide release in sympathetic neurons, and could transform how we detect and treat some cardiovascular
diseases.

Public health relevance
Project Narrative Cardiovascular disease is the leading cause of death worldwide, and the overactivity of the sympathetic nervous system (the “fight or flight” branch of the autonomic system) plays a key role in the pathogenesis or progression of numerous cardiovascular diseases. In this project we will use high-resolution, live-cell imaging techniques to visualize the changes that occur in sympathetic neurons during disease states. An increased understanding of the molecular underpinnings that are responsible for sympathetic neuron overactivity can help in earlier diagnosis and prevention of cardiovascular diseases, as well as enhance our ability to develop novel therapies.